Core C Molecular Informatics Core

Abstract
Molecular Informatics Core
The Molecular Informatics Module will provide assistance with proteomic and metabolomic/isotopomic research strategies
and technologies to the investigators involved in this P30 Cole Eye Vision Research Core. The time required to develop
expertise in proteomic and metabolomic technologies often generates research roadblocks to capable investigators with
other specialized skills. Specifically, the module will provide 1) experimental design consultation, technical support, and
data analysis for global and targeted protein quantitation in normal and diseased ocular tissues and cell systems, including
proteomic bioinformatics; 2) a centralized resource for proteomic research strategy and technical support for vision science
studies involving protein identification, protein-protein interactions and posttranslational modifications; 3) experimental
design consultation and technical support for metabolomic profiling in normal and diseased ocular tissues and cell systems;
and 4) a centralized resource for metabolomic research strategy and technical support for vision science studies, including
metabolomic bioinformatics. This core module will support NEI R01-funded investigators, help newly recruited
investigators obtain data for NEI R01 grant submissions, foster collaborative interactions between RO1-funded investigators
and newly recruited investigators, attract investigators from other departments to research on the visual system and be a
valuable departmental resource in attracting additional vision scientists to our program as we expand our research faculty.